LFFM 2 IDALS

Overall Summary
The Iowa Department of Agriculture and Land Stewardship (IDALS) proposes to partner with the
FDA through the Laboratory Flex Funding Model (LFFM) to enhance the capacity and capabilities of
state human and animal food testing laboratories supporting an integrated food safety system.
IDALS compliance of the FDA’s requirements will benefit the FDA by enabling IDALS to develop and
implement standards, maintain best practices, enhance food safety, and reduce illnesses
attributed to various food safety hazards. By maintaining ISO/IEC 17025:2017 accreditation, the
data will come from a quality system that delivers results that are recognized as high-quality and
will be immediately enforceable, thus increasing food security through an integrated food safety
system that is effective and efficient.
IDALS' overall strategy to meet the goals of the LFFM is to expand IDALS testing capabilities and
capacity, purchase additional equipment, validate new methods, and test human and animal food
samples.

Public health relevance
Iowa Department of Agriculture and Land Stewardship LFFM - Expanding Capabilities and Capacities Narrative This proposal supports the enhancement of an integrated food safety system through expanded microbiological and chemical testing of human and animal food. Development of new methods and new equipment will increase testing capabilities and capacity, ensuring the laboratory is prepared and equipped to respond during foodborne emergencies. These activities will improve human and animal health by decreasing exposure to foodborne hazards.